Expanding sexual orientation and gender identity data collection to enable improved patient care

(from parent grant)
)& .*44*0/ 0' 5)& *%/&: *..&- "/$&3 &/5&3 *4 50
(0"-4 "3& 3&"-*;&%
5)306() 6/*26& 453&/(5)4 */ "%%3&44*/( $"/$&3 130#-&.4 5)306() $0--"#03"5*0/ "$3044 #"4*$ $-*/*$"- "/%
1016-"5*0/ 3&4&"3$) %*4$*1-*/&4 4 " ."53*9&% $0/4035*6. $"/$&3 $&/5&3 -&7&3"(&4 5)& */5&--&$56"-
453&/(5) 0' %*4$07&3*&4 0' .&.#&34 "5 )0."4 &''&340/ !/*7&34*5: ! 3&9&- !/*7&34*5: ! $)00-4 0'
&%*$*/& "/% 6#-*$ &"-5) "/% "/,&/"6 /45*565& '03 &%*$"- &4&"3$) 91&35*4& *4 $-645&3&% */50 '*7&
."+03 &4&"3$) 30(3".4 580 0' 8)*$) "3& *4$*1-*/& "4&% 30(3".4 "/% 5)3&& 0' 8)*$) "3& *4&"4& 3*&/5&%
30(3".4 /05"#-& '&"563& 0' 30(3".4 *4 5)"5 &"$) *4 $0.13*4&% 0' )*()-: */5&(3"5&% #"4*$ $-*/*$"- "/%
1016-"5*0/ 3&4&"3$)&34 803,*/( 50(&5)&3 0/ 3&4&"3$) "3&"4 5)"5 "%%3&44 5)& $"/$&3 "440$*"5&% /&&%4 0' 5)&
$"5$).&/5 "3&" )*4 *4 "/ */5&/5*0/"- 4536$563& 5)"5 '635)&3 #-0440.&% 6/%&3 5)& (6*%"/$& 0' /&8
-&"%&34)*1 "/% 5)& 3&7*5"-*;&% 95&3/"- %7*403: 0"3% *7&/ 5)& )&"-5) 3&4&"3$) "/% $"3& '0$64 0' 5)&
1"3&/5 6/*7&34*5: ! 5)*4 .&$)"/*4. 0' 30(3". */5&(3"5*0/ .*33034 5)& 4530/( 53"/4-"5*0/"- '0$64 "/%
*/5&3%*4$*1-*/"3: /"563& 0' 5)& 03("/*;"5*0/ 65*-*;&4 5)& 3"/4%*4$*1-*/"3: /5&(3"5*0/ 0' 016-"5*0/
$*&/$& .&$)"/*4. "4 " )*()-: 41&$*"-*;&% $3044 $655*/( 03("/*;"5*0/"- 4536$563& 5)"5 )"4 5)& #&/&'*5 0'
"--08*/( 1016-"5*0/ 4$*&/5*454 50 3&."*/ 130(3".."5*$"--: */5&(3"5&% */50 30(3".4 8*5) #"4*$ "/% $-*/*$"-
3&4&"3$)&34 "4 8&-- "4 1307*%*/( " 1-"5'03. '03 $6-5*7"5*/( /&8 1016-"5*0/ 03*&/5&% 453"5&(*&4 5)"5 $"/ #&
%&1-0:&% "$3044 "-- 30(3".4 )&."5*$ 803,*/( (30614 "-40 &9*45 5)"5 -*/, 46#41&$*"-5*&4 "$3044 30(3".4 */
"%%*5*0/ 50 )"3&% &4063$&4 5)"5 1307*%& &9$&15*0/"- &91&35*4& 4&37*$&4 "/% 5&$)/0-0(*&4 3&26*3&% '03 -&"%*/(
&%(& */7&45*("5*0/ "/% )*() 4$*&/5*'*$ *.1"$5 !/%&3 5)& /&8 *3&$503 3 /6%4&/ "110*/5&% "/6"3:
4)"31&/&% '0$64 0/ "%%3&44*/( $"5$).&/5 "3&" /&&%4 /63563&% 53"/4%*4$*1-*/"3: 3&4&"3$) &91"/%&%
3&4&"3$) $"1"#*-*5*&4 &95&/%&% 0653&"$) "/% $-*/*$"- 3&4&"3$) */50 5)& $0..6/*5: "/% &/)"/$&% 5)& 1"$& 0'
#&/$) 50 #&%4*%& %*4$07&3: )& 30"%."1 '03 5)& .*44*0/ *4 1"7&% #: " 453"5&(*$ 1-"/ %&&.&%
%&7&-01&% #: 3 /6%4&/ "/% )*()-: &/("(&% &"%&34 !/%&3 3 /6%4&/<4 -&"%&34)*1
*/$3&"4&% .&.#&34)*1 5)& 1"$& "/% #3&"%5) 0' *.1"$5'6- %*4$07&3: #&/$) 50 #&%4*%& 53"/4-"5*0/ $-*/*$"- 53*"-
"$5*7*5: $"/$&3 '0$64&% '6/%*/( $"1"$*5: 50 "%%3&44 5)& $"/$&3 /&&%4 0' 5)& $"5$).&/5 "3&" "/% 5)& 07&3"--
*.1"$5 0' 5)& &/5&3 633&/5 "*.4 "3& 50 *4$07&3 5)& .0-&$6-"3 #"4*4 0' $"/$&3 %&7&-01.&/5 130(3&44*0/
*/ %*7&34& 1016-"5*0/4 5)306() */5&(3"5*0/ 0' #"4*$ 1016-"5*0/ "/% $-*/*$"- 3&4&"3$) &7&-01 ,/08-&%(& */50
&''&$5*7& /&8 13&7&/5*0/ %&5&$5*0/ "/% 53&"5.&/5 453"5&(*&4 '03 $"/$&3 &.1)"4*;*/( $"5$).&/5 "3&" /&&%4
*44&.*/"5& 5)306() 1"5*&/5 &%6$"5*0/ "/% 53"*/*/( 0' -"#03"503: #"4&% 1016-"5*0/ "/% $-*/*$"- 4$*&/5*454
&-*7&3 "/% &/)"/$& "$$&44 50 5)& .045 "%7"/$&% $"/$&3 $"3&

Public health relevance
Project Narrative (from parent grant) The overarching goal of the Sidney Kimmel Cancer Center (SKCC) is to leverage research expertise to reduce the overall incidence, burden, and mortality from cancer in Greater Philadelphia and beyond. SKCC goals are realized through unique strengths in addressing cancer problems through collaboration across basic, clinical, and population research disciplines. SKCC is nucleated at Thomas Jefferson University (TJU) and enriched by fully integrated research consortium partners from Drexel University (DU)'s School of Medicine and School of Public Health and the Lankenau Institute for Medical Research (LIMR); building on these strengths, SKCC focuses on addressing catchment area needs through nurturing transdisciplinary research, expanding innovative research capabilities, extending outreach and clinical research into the community, and enhancing the pace of bench-to-bedside discovery.